Administrative Core

PROJECT SUMMARY/ABSTRACT: Administrative Core
The leadership of the Vanderbilt University Medical Center TBEL Center builds on an existing multidisciplinary
team that has been working together for over 15 years on the Vanderbilt-Ingram Cancer Center (VICC) GI
Special Programs of Research Excellence (SPORE), as well as the Human Tissue Atlas Network (HTAN) that
has been in existence for four years. We have also recruited Dr. Cynthia Sears from Johns Hopkins to round out
expertise for this application. Each team member also has extensive experience in collaborative research efforts
across multiple studies and multiple institutions. The Administrative Core will provide the primary scientific
oversight for the Vanderbilt TBEL activities. It will have primary management and oversight responsibility for all
TBEL activities, which include reviewing and regulating financial expenditures, creating and preparing necessary
reports, internal and external communications, research coordination, and ensuring compliance with all federal
regulations and reporting requirements (including NIH public access policy). Thus, the Administrative Core
directly supports all members and organizational components of the TBEL Center, including the three Projects
and the two Cores - the Human Pre-Cancer Models (HPM) Core and the Quantitative Bioscience Core (QBC).
The Administrative Core will coordinate collaborations with NCI and other TBEL Centers. Our team has extensive
experience working within NCI-funded networks. As the funded TBEL Centers are developed, there will be
multiple opportunities to find shared aims and potential new collaborative projects in which the Vanderbilt TBEL
will enthusiastically participate and even lead. The Administrative Core will also ensure full compliance with the
data and resource sharing plans agreed upon with NCI and the TBEL Centers. This will be accomplished by
working closely with the QBC to ensure that all relevant data and tools are transferred securely and in a timely
manner to the TBEL data coordinating center. During the initial development of the TBEL Center, the Project
and Core Leads and Co-Leads will work closely with NCI and the other TBEL Centers. Based on our past
experience and present shared vision, we are fully committed to the success of the TBEL Center.